Genomics Shared Resource

GENOMICS SHARED RESOURCE (GSR)
PROJECT SUMMARY/ABSTRACT
The Genomics Shared Resource (GSR) provides UC Davis Comprehensive Cancer Center (UCDCCC)
researchers with comprehensive services and expertise in the broad area of genomics and bioinformatics, and
access to the most contemporary genomic applications and state-of-the-art instrumentation for next-generation
sequencing (NGS) and NanoString nCounter analyses. Together, these technologies enable investigators to
accomplish virtually every type of genomics application including mutation screening (whole-exome
sequencing; WES), transcriptome profiling (RNA-Sequencing), epigenomics (ChIP-Seq, Hi-C), metagenomics,
and single-cell sequencing. The GSR also provides a wide range of services for translational genomics
research with optimized protocols for the analysis of clinical samples from a broad range of sources (e.g.,
FFPE tissue, whole blood, serum, saliva, patient-derived xenografts) and of extremely limited amounts.
Moreover, investigator-driven projects have been supported by the development of customized protocols and
reagents, including targeted NGS panels and methods for the analysis of circulating tumor DNA, exosomal
miRNA, and viral genomes. To help achieve productive outcomes from genomics experiments, the GSR
provides extensive data analysis and integrative bioinformatics support. The GSR further facilitates these
projects by providing consultation for experimental design, project logistics and management, as well as
support for the preparation of manuscripts and grant proposals. Education is an additional important
component of the GSR and is provided through laboratory-based training, workshops, and seminars. Oversight
and management of the GSR is provided by the Director, John McPherson, PhD, who has deep expertise in
DNA sequencing and cancer genomics through the Human Genome Project and a career that spans three
Genome Centers; and the co-Director, Clifford Tepper, PhD, who has 20 years of experience in the
application and development of a wide variety of genomics and bioinformatics applications. Taken together, the
GSR provides a complete integrative and functional molecular profiling solution to the UCDCCC. The Specific
Aims for the GSR are to: 1) Provide services, expertise, and technologies in the area of genomics to UCDCCC
investigators. 2) Perform bioinformatics analysis in order to provide interpretable results from genomics
studies. 3) Facilitate the genomics research efforts of the UCDCCC through education, mentoring and support
for preparation of manuscripts and grant proposals. 4) Facilitate access to other `omic services at UCDCCC.